Extraction and summarization of evidence-based medicine

Project Summary/Abstract
Evidence-based medicine (EBM) requires collecting and ranking relevant evidence according to its
epistemological strength, aiming to identify the most suitable evidence to inform guidelines and policies. This
process generally prioritizes strong evidence from randomized clinical trials (RCTs), cohort studies, systematic
reviews, and meta-analyses. However, the volume of scientific literature being published in peer-reviewed
journals is increasing exponentially. This makes it extraordinarily financial and societal costly for scientists to
obtain a reasonably precise, cumulative overview of the conceptual structure of the literature about a certain
scientific topic, and to identify potential new research opportunities. It also presents a challenge for practitioners
and policymakers in assimilating and understanding the prevailing findings, further slowing down the translation
from biomedical discoveries to improved health outcomes. It is imperative to develop scalable methods for
efficient clinical evidence extraction and summarization. Responding to PA-23-034, this project will develop and
validate a novel informatics framework to extract computable Population, Intervention, Comparison, and
Outcome (PICO) elements and summarize them from publications of interventionaland observational studies.
While the framework can be applied to any type of condition, the focus will be on 23 clinical domains, such as
neurological, respiratory, digestive system, cardiovascular, and mental health conditions, because they are
extremely common and affect people of all ages, races, and socioeconomic statuses. Our extensive preliminary
data show that we can effectively employ deep learning (DL) and natural language processing (NLP) methods
to extract PICO elements from the clinical trial registries and RCT publications in PubMed. We can also perform
zero-shot clinical evidence summarization across six clinical domains. These studies lend further support to the
feasibility of the proposed research. Based on our preliminary data and our experience with an interdisciplinary
team, our specific aims are: (1) Systematically design and data-driven evaluate a computable PICO ontology;
(2) Extract multi-granular PICO elements from study publications; (3) Generate rational-based evidence
summaries; and (4) Develop and validate the EBM toolkit via a user-centered design. The research proposed in
this project is novel and innovative because it will produce and rigorously test new solutions to improve
computable EBM. Successful completion of these aims will empower the general public, stakeholders in EBM,
and public health policymakers to efficiently discover and summarize pertinent medical evidence, thereby
facilitating well-informed healthcare decision-making.

Public health relevance
Project Narrative The proposed research is relevant to public health because it transforms free-text clinical evidence in the literature into a computable format that can better support evidence extraction and summarization. It applies natural language processing to unstructured biomedical literature to support evidence-based clinical research and to enhance the health of the public. The proposed research is also relevant to the part of the NLM's strategic plan that focuses on (1) development and demonstration of innovative informatics methods and data science techniques for informing public health, (2) advanced information retrieval and knowledge discovery from very large and/or heterogeneous data sets